09 Breast Cancer Research Program

BREAST CANCER RESEARCH PROGRAM (BCRP): PROJECT SUMMARY
The long-term goals of the Breast Cancer Research Program (BCRP) are to define the fundamental mechanisms
that regulate breast cancer pathology and then use this information to develop personalized strategies for the
prevention, diagnosis, and treatment of all stages and subtypes of breast cancer. The BCRP leadership
established collaborative working groups in clinical, basic, and population sciences to identify and develop novel
implementation strategies for the diagnosis and treatment of breast cancer. These three groups are guided by
the hypothesis that advances in basic and population sciences can be leveraged to enhance the clinical impact
in successfully treating breast cancer. These translational efforts have been organized around three specific
aims. Aim 1. Discover, identify, and validate novel personalized clinical targets for breast cancer. Aim 2. Utilize
institutional expertise in basic sciences to define the molecular mechanisms that drive breast cancer progression
and metastasis in individuals. Aim 3. Reduce disparities in breast cancer mortality by identifying personalized
risk factors and developing targeted prevention and genomic strategies.
The BCRP contains 19 members from four departments and two schools. Current funding exceeds $7.9
million, with $3.0 million from the NCI and $1.8 million from other peer-reviewed funding. BCRP members
published 456 papers during 2014-2018, with 42% inter-programmatic publications and 24% intra-programmatic
publications; that included contributions to Cell, Nature, Nature Communications, Nature Genetics, Cell Reports,
Journal of Clinical Investigation, Journal of Clinical Oncology, and Journal of the National Cancer Institute. The
broad-ranging achievements and future objectives of the BCRP can be organized into three main research areas:
clinical and translational research, basic research, and disparities-based research.